The Role of RBC Reactive Oxygen Species in Regulating Thrombotic Events During Aging

The Role of RBC Reactive Oxygen Species in Regulating Thrombotic Events During Aging
Abstract:
Seventy percent of mid-life stage (older) adults have already been diagnosed with at least one chronic
condition. As such, venous thrombosis/thromboembolism (VT/E) is up to 7 times higher in adults over 55
years old, compared to a younger cohort. VT/E affect over one million Americans per year. In light of an
increasing life expectancy, development of chronic diseases will become a greater health care issue.
Despite this, the key risk factors contributing to increased risks for developing chronic diseases in older
adults remain unclear. Thus, it is critical to identify drug-targetable causative mechanisms predisposing
older adults to develop chronic diseases to reduce these risks. Oxidative stress is one of the hallmarks of
aging, and a critical contributor to VT/E. In aging, while studies have extensively focused on oxidative
stress in the vasculature, the role of oxidative stress in RBCs predisposing to VT/E has been neglected.
We now provide preliminary evidence for a unique activated pathogenic mechanism intrinsic to RBCs
that can initiate prothrombotic pathways in older adults. RBCs from older (58-68 years old) adults show
excessive reactive oxygen species (ROS) mediating adhesive and prothrombotic processes in vitro
compared to RBCs from younger (21-30 years old) adults. Increased RBC ROS were generated by
NADPH oxidases (Noxs), and involved RBC GRK2 activation. This suggests that aging adversely
modifies RBC adhesive and prothrombotic potentials through GRK2/Nox/ROS . We also discovered that
small non-coding nucleolar RNAs (snoRNAs) from the Rpl13a gene locus regulate RBC ROS-mediated
thrombus formation in aged mouse models in vivo. We hypothesize that RBC GRK2/Nox/ROS pathway
in older adults activates RBC adhesive and prothrombotic phenotypes, by which venous thrombosis (VT)
may occur in the aging population. We further hypothesize that this ROS pathway is regulated by RBC
Rpl13a snoRNAs, and that inhibition of this pathway can reduce adhesive and procoagulant processes.
To test our hypotheses, we propose to use blood samples from older (55-65 years old) and younger (21-
30 years old) adults, and aged mouse models with the equivalent of human ages, and determine: SA1)
that RBC GRK2/Nox are involved in the molecular and cellular bases by which VT may occur in aging,
and that targeting GRK2/Nox pharmacologically and genetically will reduce RBC adhesive and
prothrombotic potentials; SA2) that Rpl13a snoRNAs regulate RBC ROS pathway and downstream
events in aging; and SA3) the transcriptomic changes dysregulating RBC ROS levels triggering
procoagulant pathway in aging. Our studies will provide novel insights into the exact RBC mechanisms
contributing to prothrombotic pathway in aging, and may identify novel targetable RBC anomalies to
prevent prothrombotic cascade activation, thus laying the foundation for more rational therapeutic
strategies that better reduce the risks for VT/E in mid-life stage adults with exaggerated oxidative stress.

Public health relevance
Project Narrative: Relevance Mid-life stage adults are at high risk for developing venous thrombosis/thromboembolism (VT/E). Identifying novel targets for development of new effective therapies is critical to reducing risks predisposing the aging population to VT/E. We propose to test the hypothesis supported by our preliminary data, that excessive production of reactive oxygen species and the mechanism by which they are regulated in red blood cells of mid-life stage adults activate prothrombotic cascade, and that inhibiting this mechanism pharmacologically or genetically may reduce VT/E risks in the aging population with high oxidative stress.